Identifying genetic variants that modify the effect size of ApoE alleles on late-onset Alzheimer's disease risk

PROJECT SUMMARY/ABSTRACT
Studying genetic contributions to dementia risk from both the population-specific and trans-ancestral
perspectives is vital to disease prediction, characterization, and the development of treatment interventions.
Late-onset Alzheimer’s disease (LOAD) is the most common form of dementia, costs the United States an
estimated $305 billion in associated costs, and affects approximately 6 million individuals nationally, and more
than 24 million people globally. Apolipoprotein E (ApoE) is the strongest known genetic risk factor for LOAD.
Specifically, ApoE-associated LOAD risk is driven by a risk variant of ApoE (termed ε4 or ApoE4) while ApoE-
associated LOAD protection is thought to be driven by a protective variant of the gene (termed ε2 or ApoE2).
The allele frequency of these alleles varies across populations, partially explaining higher LOAD prevalence in
populations of African descent who carry the highest ApoE4 allele frequencies. In contrast to these findings,
evidence indicates ApoE4-associated LOAD risk is significantly lower in individuals of African descent
compared to other groups. This effect modification is partially driven by population-specific local ancestry that
modifies the effect size of ApoE4. This observation, however, does not fully explain the reduction in effect size
in African Americans. I hypothesize that genetic variants (local and global) modify ApoE4 and ApoE2 effect
sizes. This proposal describes three aims to address the investigation into genetic contributions to ApoE-
associated LOAD risk in multiple, diverse populations. Aim 1 will document the relationship between LOAD risk
and the ApoE4 and ApoE2 alleles in the largest and most diverse dataset to be studied to date by estimating
effect sizes in each of several diverse populations. Aim 2 will identify SNPs that associate with extreme ApoE4
and ApoE2 effect sizes and test whether these SNPs define specific physiological pathway association. Finally,
aim 3 will evaluate the relative roles of race/ethnicity and genetic variation as modifiers of effect sizes within
and between populations. As an MD/PhD candidate, I am passionate about this project as it will lead to new
insights that can be used to understand, identify, and predict LOAD risk in underserved populations in the
United States, especially those that experience increased LOAD burdens. The combined educational support
from the Population and Quantitative Health Sciences Department and clinical training from the Medical
Scientist Training Program at Case Western Reserve University will prepare me in tackling the genetic and
healthcare avenues this work aims to inform. With support from these sources, and committee members with
expertise in population genetics, statistical analysis, and bioinformatics, my training will provide the skills
necessary to become a physician scientist versed in rigorous statistical approaches to understanding
contributions to complex diseases.

Public health relevance
PROJECT NARRATIVE Apolipoprotein E (ApoE) represents the most significant genetic risk factor for Late-onset Alzheimer’s disease (LOAD), the most common type of dementia that affects more than 6 million people in the United States. However, even though the same ApoE allele confers risk in all populations, the effect sizes differ significantly by genetic ancestry. The proposed research aims to identify variants and physiological pathways that modify ApoE-associated LOAD risk in non-Hispanic Black, Hispanic/Latino, and non-Hispanic White individuals and evaluate the roles of race/ethnicity and ancestry in LOAD risk modeling.